West Virginia University Stimulating Access to Research in Residency

ABSTRACT
The need for innovative health solutions in West Virginia (WV) is urgent. WV has one of the highest poverty rates
in the nation, is the only state located entirely within Appalachia, and its residents have among the poorest acute
and chronic health outcomes in heart, lung, and blood diseases and disorders. The predominantly rural
population provides unique opportunities for crucial health-related research but has been short-changed by
historic low inclusion in clinical research studies. The Mountaineer Stimulating Access to Research (Mountaineer
StARR) program will catalyze the career development of clinician-investigators through new research
opportunities created, organized, and delivered to medical residents via robust didactic offerings and mentored
research training. The overarching goal is to reduce the burden of health disparities among West Virginians by
growing the next generation of clinician-investigators. Selected medical residents will have an opportunity to
extend their residency training to include a 15-month intensive research experience with 80% protected time for
research training and data collection. In addition, StARR Resident-Investigators will simultaneously earn a
Master of Science (MS) in Clinical and Translational Sciences (CTS) offered by the West Virginia Clinical and
Translational Science Institute (WVCTSI). Collaborations with other established research engagement and
training programs at West Virginia University (WVU) will support the aims of this program by leveraging existing
resources and services to create synergy for clinician-investigators. The focus will be on recruitment, retention,
and accelerating research independence for Resident-Investigators. The WVU Health Sciences Center currently
offers residents opportunities for elective research and pursuit of a MS CTS; however, substantial protected time
for research is not available. The 4-year long research-intensive Mountaineer StARR program will bridge this
resource gap and attract and prepare residents to become clinician-investigators. The selected R38 Resident-
Investigators will have access to a large pool of mentors who have strong records of accomplishment in
mentoring early career stage clinician-investigators. Moreover, acceleration of research independence will be
achieved by providing protected research time, experienced mentorship, didactic training in clinical and
translational sciences, and formal grant writing support for submission of an NIH K38 Transition Scholar Award.
In addition, the program aims to retain residents by providing them with a vibrant and growing research
community that has an exceptional infrastructure for supporting the professional development of early-stage
investigators. This sustained commitment to the development of clinician-investigators will enable WVU to “grow
our own” research talent within WV. By empowering Resident-Investigators with the professional skills needed
to conduct research in heart, lung, blood and sleep disorders, this program will be an important step forward in
addressing the health disparities in the rural communities of WV, Appalachia and the nation.

Public health relevance
Addressing the prominent health disparities in West Virginia and Appalachia depends on the recruitment, training and retention of clinician-investigators committed to rural health. Via robust didactic offerings, mentored research support, and protected time for research, the Mountaineer StARR program will accelerate research independence among medical residents with an interest in the treatment and prevention of heart, lung, blood, and sleep diseases and disorders. This program offers potential benefits to the selected residents, the institution, and our underserved population.